Histopathology Core

The NEI Histopathology Core processes human from donor and animal tissue, mainly ocular tissue, collected by NEI researchers to research human eye disease. The Histopathology Core processes these tissues for microscopy, sectioning it and staining slides for bright field, fluorescence and/or transmission electron microscopy. During FY2019 the Histopathology Core received and processed approximately: Electromicroscopy: 237 Electron microscopy(EM)specimens. Microscopy samples: 383 Methacrylate, 210 Paraffin, 379 cryosections and 13 Flat mount prep. for a total of 820 specimens. All the slides were imaged in Zeiss Axio Scan and save in H.C. Cloud. Additionally, the laboratory processed case materials sent for ultrastructure, producing electron microscopic images. About 95% of our effort is devoted to NEI investigators but we also accept samples to process from other institutes. The following papers, as well as those listed in the bibliography, were published using the services of the Histopathology Core: Intraocular Injection of HyStem Hydrogel Is Tolerated Well in the Rabbit Eye Randolph D. Glickman,1 Michael Onorato,2 Maria M. Campos,3 Michael P. OBoyle,4 Ratnesh K. Singh,2 Thomas I. Zarembinski,2 Francois Binette,2 and Igor O. Nasonkin2 JOURNAL OF OCULAR PHARMACOLOGY AND THERAPEUTICS Volume 37, Number 1, 2021 Mary Ann Liebert, Inc. DOI: 10.1089/jop.2020.0042 Epithelial phenotype restoring drugs suppress macular degeneration phenotype in an iPSC and a rat model (our reference 147999-JCI-RG-1) has been submitted to the Journal of Clinical Investigation. ruchi sharma (NIH), Aman George (National Institutes of Health) Malika Nimmagadda (National Institutes of Health) Davide Ortolan (National Institutes of Health) Karla Barbosa (NEI) Zoya Qureshy (National Institutes of Health) Devika Bose (National Institutes of Health) Roba Dejene (National Institute of Health)Genqing Liang (NEI) Qin Wan (NEi) Justin R. Chang (NEI)Balendu Shekhar Jha (NEI)Omar Memon (NEI) Kiyoharu Miyagishima (National Institute of Health) Aaron Rising (NEI)Madhu Lal-Nag (CDER/FDA) Eric Hanson (National Institutes of Health (NIH) Rebecca King (NIH) Mercedes Maria Campos (NEI) Marc Ferrer (NIH) Juan Amaral (NEI) David McGaughey (NEI) Kapil Bharti (NIH, NEI) Aged Nrf2-null mice develop all major kinds of age-related cataracts Sheldon Rowan1,2,3,*, Shuhong Jiang1, Sarah G. Francisco1, Laura CD Pomatto4, Zhiwei Ma5, Xiaodong Jiao5, Maria M Campos6, Sandeep Aryal7, Shaili Patel7, Binapani Mahali8, S. Amer Riazuddin9, Elia J. Duh8, Salil A. Lachke7, J. Fielding Hejtmancik5, Rafael de Cabo4, Paul G. FitzGerald10, and Allen Taylor1,2,3,* submitted Rs1h-/y exon 3-del rat model of X-linked retinoschisis with early onset and rapid phenotype is rescued by RS1 supplementation Yong Zeng, Haohua Qian, Maria Mercedes Campos, Yichao Li, Camasamudram Vijayasarathy1, and Paul Sieving Paper #GT-2021-00143RR, Juweid ME, Tulchinsky M, Abu-Asab M, Mottaghy FM. Proposal for greater balance and inclusion in ranking nuclear medicine journals. Eur J Nucl Med Mol Imaging. 2021 May;48(5):1291-1292. doi: 10.1007/s00259-021-05263-w. PMID: 33674896. Bullock J, Polato F, Abu-Asab M, Bernardo-Coln A, Aflaki E, Agbaga MP, Becerra SP. Degradation of Photoreceptor Outer Segments by the Retinal Pigment Epithelium Requires Pigment Epithelium-Derived Factor Receptor (PEDF-R). Invest Ophthalmol Vis Sci. 2021 Feb 1;62(2):30. doi: 10.1167/iovs.62.2.30. PMID: 33605986; PMCID: PMC7900850. arghese PK, Abu-Asab M, Dimitriadis EK, Dolinska MB, Morcos GP, Sergeev YV. Tyrosinase Nanoparticles: Understanding the Melanogenesis Pathway by Isolating the Products of Tyrosinase Enzymatic Reaction. Int J Mol Sci. 2021 Jan 13;22(2):734. doi: 10.3390/ijms22020734. PMID: 33450959; PMCID: PMC7828394. Leal LF, Szarek E, Berthon A, Nesterova M, Faucz FR, London E, Mercier C, Abu-Asab M, Starost MF, Dye L, Bilinska B, Kotula-Balak M, Antonini SR, Stratakis CA. Pde8b haploinsufficiency in mice is associated with modest adrenal defects, impaired steroidogenesis, and male infertility, unaltered by concurrent PKA or Wnt activation. Mol Cell Endocrinol. 2021 Feb 15;522:111117. doi: 10.1016/j.mce.2020.111117. Epub 2020 Dec 15. PMID: 33338547 Pigment epithelium-derived factor (PEDF) and derived peptides promote survival and differentiation of photoreceptors and induce neurite-outgrowth in amacrine neurons Germn Michelis, Olga Lorena German, Rafael Villasmil, Tamara Soto, Nora P. Rotstein, Luis Politi, S. Patricia Becerra First published: 16 June 2021 https://doi.org/10.1111/jnc.15454 Journal of Neurochemistry